The Role of m6A-RNA Methylation in Memory Formation and Recall and Its Modulation and Influence on Long-Term Outcomes as a Consequence of Early Life Lead Exposure

Regulation of transcription is central to proper nervous system development and functioning. Dysregulation of
transcriptional and post-transcriptional regulatory pathways are associated with various neurodevelopmental
diseases and disorders including developmental lead (Pb) exposure, which often results in significant and
persistent cognitive and behavioral deficits. We have previously reported Pb-induced methylation changes at
gene promoter regions and effects of Pb on various post-translational histone modifications (PTHMs) in hippo-
campus (HIPP) and medial prefrontal cortex (mPFC) in animals with Pb-induced cognitive dysfunction, with
sex, amount of Pb exposure, and developmental window of exposure as effect modifiers. While prior work has
focused on effects of Pb on DNA-related mechanisms, an additional molecular transcriptional control
mechanism that has not been studied in this regard is RNA modification. Preliminary data from our lab support
the hypothesis that direct RNA methylation via N6-methyladenosine (m6A/m), may be an important mechanism
contributing to the functionally altered transcriptome after developmental Pb exposure. Direct modifications of
RNA appear to provide an additional layer of control over RNA function for the fine-tuning of transcriptomic
responses to the environment, critical for normal plasticity and memory function. Considering the negative
impact that Pb exposure has on neural plasticity and memory, we suggest that there is a potentially important
role of m6A/m in post-transcriptional regulation of gene-specific responses associated with Pb-induced
plasticity/ memory impairments. Our hypothesis is that this abundant epitranscriptomic mark, m6A/m, not only
plays an important role in modulating memory processes under normal circumstances but is altered by early
Pb exposure with an adverse influence on transcriptional and behavioral responses to Pb. We will test this
hypothesis in the following aims: Aim1: Examine the extent to which transcriptome-wide m6A/m profiles in
mPFC and HIPP CA1 and are altered by developmental Pb exposure in males and females and associated
with expression of memory deficits. Hypothesis: There will be brain region-distinct transcriptome-wide
enrichment profiles of m6A/m (detected by m6A-eCLIP (enhanced UV-crosslinking and immunoprecipitation),
particularly associated with memory/plasticity-related genes and pathways, that are aberrantly modulated in
Pb-exposed, memory-impaired animals; Aim2: Examine the functional significance of m6A/m modification in
mPFC and CA1 in Pb-exposed animals through manipulation of m6A/m levels. As preliminary data indicate
decreased m6A levels and increased FTO expression in Pb-exposed rats with memory deficits, we will explore
the potential efficacy of viral-mediated targeted knockdown of FTO on Pb-induced memory impairments and
m6A/m levels and memory/plasticity-related gene expression in mPFC and CA1. We hypothesize that by
increasing m6A/m levels we will at least partially ameliorate the Pb-induced memory impairment.

Public health relevance
Developmental lead exposure is still a significant public health problem resulting in long-term adverse cognitive and behavioral outcomes, yet the mechanisms through which lead causes these adverse outcomes are still not completely known. At the basic science level, understanding the molecular mechanisms that may be involved in the adverse effects of lead on the brain and behavior is important and will be addressed in proposed work by studying, for the first time, the effects of developmental lead exposure on a novel epitranscriptomic mechanism involving direct modification of RNA and its influence on gene expression levels and behavioral responses following developmental Pb exposure. The proposed studies will add a new dimension to the understanding of gene-environment interactions following developmental Pb exposure and set the stage for further studies that may ultimately impact treatment of Pb-induced cognitive/ behavioral dysfunction.